CRYSTALLOGRAPHIC STUDIES OF INTERLEUKIN 5 RECEPTOR

We have crystallised the extracellular domain of the beta subunit of the interleukin-5 receptor. This is an important cytokine receptor that has been implicated in the pathogensis of asthma and certain parasite infections. The crystals are weakly diffracting and it can take up to 10 days to collect a complete dataset on a rotating anode source. The effective resolution of the crystals is limited by the signal to noise ratio of the data collection system, being -3.5A on a rotaing anode and -2.6A on a synchrotron. In order to facilitate derivativisation, a number of cysteine mutants have been produced. Some of the mutant crystals grow only to a small size. These do not diffract when a rotating anode source is used. It has been shown that these crystals produce usable diffraction on 14 BM-C.